Center for AIDS Research at Emory University

PROJECT SUMMARY/ABSTRACT
This application is for the competitive renewal of the Center for AIDS Research at Emory University (Emory
CFAR). Since first funding in 1997, the Emory CFAR has risen to preeminence in the HIV research community,
through the development and support of its members. Emory CFAR Members possess broad expertise
representing the full scientific spectrum needed to accelerate HIV science from the bench to the bedside to
the communities we serve. Emory CFAR organizes this expertise into five research focus areas: Basic
Research, Pre-Clinical Research, Clinical Research, Prevention Science, and Public Health. These focus
areas are served by an Administrative Core, a Developmental Core, five Science Cores (Biostatistics and
Bioinformatics; Clinical Research; Prevention and Implementation Sciences; Systems Immunology; and
Virology and Molecular Biomarkers); and two Scientific Working Groups (SWGs) - Health Equity and Next
Generation Therapeutics.
The Emory CFAR is uniquely poised—geographically and scientifically—to achieve our mission. We are
located at the epicenter of four high burden counties as defined by Phase I of the Ending the HIV Epidemic
Initiative. These metro-Atlanta counties are home to almost 3.5M persons (54% African American; 5.2%
Hispanic/Latinx), representing one-third of Georgia's population. Our physical location allows CFAR Members
to apply the scientific tools necessary to achieve the EHE goals and advance the NIH research priorities. Given
the high burden of HIV in our geographical region, coupled with clear inequities in access to healthcare in the
communities we serve, the Emory CFAR is committed to working toward equity in all aspects of
research, faculty development, and community engagement. We will intentionally seek to recruit and
develop a cadre of URM investigators in collaboration with our colleagues at Morehouse School of Medicine,
and we will continue to elevate the role of the CFAR Community Liaison Council, expanding their influence
within the CFAR to guide best practice for the dissemination of HIV research findings and together, we will
strive to build community trust in research through the intentional inclusion of key stakeholders at all stages of
the research pipeline. The Emory CFAR proposes the following Specific Aims:
Aim 1. Advance groundbreaking HIV research across the entire scientific spectrum of NIH-defined priority
research areas to end the epidemic for all and to promote health equity.
Aim 2. Cultivate cutting-edge tools and services to support transdisciplinary research teams.
Aim 3. Develop and train the next generation of outstanding and diverse HIV investigators.
Aim 4. Elevate multidirectional community stakeholder engagement to improve the well-being of people living
with and at risk for HIV across their lifespan.

Public health relevance
PROJECT NARRATIVE The Emory CFAR will contribute to ending the HIV epidemic by accelerating the highest caliber translational research — fostering team science, equity, and multidirectional stakeholder engagement. We will strive to build community trust in research through the intentional inclusion of key stakeholders at all stages of the research pipeline. We will achieve our goals by providing innovative services, tools, expertise, and access to state-of- the-art equipment through an Administrative Core, a Developmental Core, five Science Cores (Biostatistics and Bioinformatics; Clinical Research; Prevention and Implementation Sciences; Systems Immunology; and Virology and Molecular Biomarkers); and two Scientific Working Groups (SWGs) - Health Equity and Next Generation Therapeutics.